Germ-line miRNA binding site variants as biomarkers of toxicity and response to checkpoint inhibition

PROJECT SUMMARY
There is an incredible, desperate need to find new biomarkers to improve our ability to personalize cancer
therapy, to identify responders, and, perhaps more importantly, to identify those that will experience toxicity
from treatment in the context of response and non-response. This need has led to Provocative Question #8,
asking us to investigate: What are the predictive biomarkers for the onset of immune-related adverse events
associated with checkpoint inhibition, and are they related to markers for efficacy?
While there have been several tumor-acquired mutations applied as biomarkers for targeted chemotherapies,
no such biomarkers have been identified that can predict toxicity to therapy. Immune-related adverse events
are likely related to the complex host-specific response to therapy, suggesting that the host's tumor may not be
the best source of biomarkers, but that instead germ-line biomarkers, that are also present in all the patient's
cells, including their immune cells, could be a much more viable source.
While global approaches to study normal DNA have been applied to find germline biomarkers, they do not
purport to identify functional biomarkers, only tagging SNPs that may be associated with functional biomarkers
elsewhere in the DNA. There is growing evidence that germline microRNA (miRNA) disrupting mutations are in
fact functional biomarkers identifying patients with altered stress responses to cancer therapy, which are not
currently included in normal DNA analyses. In this proposal, the goal is to validate the predictive power of this
new class of miRNA-based biomarkers, in two clinical trials of patients with NSCLC or HNSCC, treated with
immune therapies. The final confirmed panel of functional biomarkers will be further correlated with other
biomarkers found to help identify patients with toxicity to checkpoint therapy. Results from this proposal could
allow the identification of patients who have genetically unique immune system circuitry resulting in an altered
response to immune modulating therapies, which will allow significant progress towards answering PQ#8.

Public health relevance
PROJECT NARRATIVE Tailoring cancer therapy to allow the best cure, or response, with the fewest side effects, or toxicity, from therapy is a very high priority for cancer care. While biomarkers of response exist, functional biomarkers predicting toxicity have never been identified and applied to direct treatment. We have identified a new class of differences between people that predict toxicity to cancer treatments involving the immune system, and believe that their application has the potential to radically change how we personalize this approach to cancer treatment in the near future.